Non-canonical mechanisms of Toll-like receptor function in the chemosensory nervous system

PROJECT SUMMARY
Toll-like receptors (TLRs) are an evolutionarily ancient class of cell-surface molecules with well
characterized roles in morphogen signaling and innate immunity. In these contexts, TLRs use a canonical
signaling mechanism that involves recruitment of adapter proteins to the cytoplasmic domain of TLRs and
subsequent activation of a kinase cascade that regulates transcriptional responses. Recently, we and others
have found that TLRs are required for normal development and function of sensory circuits. Unlike morphogen
signaling and innate immunity, sensory circuit development does not require canonical TLR signaling
mechanisms. The non-canonical mechanisms by which TLRs regulate the development of sensory circuits are
unknown. I propose studies of the sole TLR encoded by the C. elegans genome, TOL-1, to reveal how non-
canonical TLR signaling regulates sensory system development and function and to identify molecular
mechanisms of non-canonical TLR signaling. My preliminary data show that TOL-1 is highly enriched in in the
developing neuropil of embryonic nervous system. Using a genetically engineered conditional allele of tol-1, I
found that depletion of TOL-1/TLR from sensory neurons causes marked defects in chemotaxis behavior. My
preliminary data further show that TOL-1 does not require its intracellular domain to function in sensory neurons,
indicating that its function is independent of canonical TLR signaling mechanisms. l will use C. elegans genetics,
genomics, and high resolution / super-resolution microscopy to (1) determine how TLRs regulate the
establishment and maintenance of sensory neuron architecture and function, (2) test the hypothesis that TLRs
that lack the ability to directly interact with intracellular partners are nevertheless able to regulate gene expression
in sensory neurons, and (3) test the hypothesis that TLR function in sensory neurons requires interactions with
specific extracellular partners. The proposed studies will advance understanding of how a highly conserved
family of cell-surface receptors functions in sensory circuits.

Public health relevance
PROJECT NARRATIVE Mechanisms that generate sensory neurons during development and integrate them into the neural circuits that control behavior are poorly understood. My studies of the C. elegans chemosensory nervous system have identified a role in this process for Toll-like receptors (TLRs) that is independent of their canonical signaling partners. I have developed methods that harness the powerful genetics and genomics of C. elegans to determine how TLRs, which are a highly conserved class of cell-surface protein, function in nervous system development.